Improving Outcomes of Older Adults with Psychosocial Vulnerability Undergoing Major Surgery

Project Summary/Abstract No Changes from the original K76 AG 059931 submission.

Public health relevance
Project Narrative No Changes from the original K76 AG 059931 submission.